Mystery of the Crooked Cell 2.0: CityLab's Next Generation SocioscientificApproach to Gene Editing

Project Summary/Abstract Boston University School of Medicine’s new SEPA project, entitled "Mystery of the Crooked Cell 2.0: CityLab’s Next Generation Socioscientific Approach to Gene Editing," addresses the imperative that NIH's pre-college activities focus on biomedical workforce preparedness. This project will reach close to 600 mostly northeastern U.S. students and, through planned dissemination, will reach thousands of students nationwide. CityLab is partnering with five Boston-area high schools and two afterschool STEM/health professions enrichment programs to test the effectiveness of embedding a focus on socioscientific reasoning (SSR) to promote understanding of gene editing. An SSR approach places science content in a meaningful social context and motivates students to take ownership of their learning. SSR skills include realizing the complexity of the content and context of an issue, analyzing an issue from multiple perspectives, seeking out sources of bias in data, and considering how and whether scientific investigations can advance understanding of an issue. This project will expand CityLab’s “Mystery of the Crooked Cell” hands-on, inquiry-based curriculum supplement that focuses on the molecular basis of sickle cell disease (SCD) by incorporating state-of-the-art gene editing content that is suffused with SSR. The new curriculum supplement, Mystery of the Crooked Cell 2.0 (MCC 2.0), will seamlessly integrate three elements: CityLab’s curriculum storyline and laboratory experiences, computer simulations of molecular biology assays developed at University of Wisconsin-River Falls, and immersive virtual reality simulations of gene editing for SCD therapies developed at UC Berkeley Innovative Genomics Institute. SSR will be embedded throughout MCC 2.0, as will awareness of STEM/biomedical science careers. CityLab will also build NextGen Scholars, a learning community that will not only engage students in advanced science content and lab applications using SSR but also builds awareness and familiarity with STEM and STEM-adjacent careers. This project will demonstrate the feasibility and replicability of this pedagogical strategy; CityLab will then disseminate the curriculum widely and thereby sow the seeds for a robust future STEM workforce. The major objectives of the proposed project are: (1) to create MCC 2.0 in collaboration with high school teachers and students, (2) to build a community of learners who use SSR to explore advanced topics in STEM and health, (3) to examine changes in students’ science content understanding, SSR skills, and science learner identity in regard to careers in the biomedical sciences and medicine, (4) to track student participants through college to understand the broader impact of this approach, and (5) to earn designation as one of the first “High-Quality Design” high school lessons that are aligned to the Next Generation Science Standards (NGSS). This new SEPA initiative is a unique way to pilot, refine, and disseminate a first-of-its-kind science education program that will increase the strength and number of individuals who pursue careers in the STEM/biomedical science workforce.

Public health relevance
PUBLIC HEALTH RELEVANCE: Many high school students lack exposure to authentic laboratory science experiences that can profoundly influence their academic performance in school and their subsequent career trajectories. Since today’s students will determine our nation’s future scientific competitiveness and need to be intelligent evaluators of new science and health advances, CityLab will use well-matched comparison studies in pre-college student populations to determine whether infusing socioscientific reasoning skill development into its new gene editing curriculum supplement will teach students important science concepts and practices and also promote continued engagement in the biomedical sciences/STEM. This project will test the hypothesis that teaching socioscientific reasoning skills, in conjunction with laboratory-based experiences and extended participation in a community of learners, will positively impact these students, promote their continued engagement in STEM, raise their awareness about careers in the health professions and biomedical sciences, and ultimately improve the nation’s understanding of gene editing and its role in improving human health and eradicating disease.